Characterizing women living with HIV at cervical cancer diagnosis in Rwanda: Mentored Research under the Rwanda CASCADE Clinical Trials Site

Title: Characterizing women living with HIV at cervical cancer diagnosis in Rwanda:
Mentored Research under the Rwanda CASCADE Clinical Trials Site
ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified
as: NOT-CA-24-028 to mentor an early stage LMIC investigator (ESLI), Dr. Eulade
Rugengamanzi, a Rwandan clinical oncologist who has demonstrated great interest in being
developed as an independent investigator. Despite the widespread roll out of anti-retroviral thrapy
(ART) under the Treat all era in most sub-Saharan African countries (SSA) where the HIV burden
is the world’s heaviest, women living with HIV (WWH) continue to also bear a heavy burden of
cervical cancer (CC). WWH still present with cervical cancer at advanced stage and little is known
about their treatment outcomes and the impact of a cancer diagnosis on HIV care and vice versa
as well as barriers to screening, early detection and diagnosis of cervical precancer and cancer.
Findings from this study will provide actionable information about the impact of HIV on CC as well
as the barriers to and facilitators of cervical-related care for WWH. This information has the
potential to inform CC prevention and treatment policy and practice in Rwanda and elsewhere in
SSA, in turn impacting the morbidity and mortality of CC in this high-risk population. This mentored
research project will allow Dr. Rugengamanzi to develop quantitative and qualitative research
skills that will provide a foundation for his development as an independent investigator conducting
high-impact cancer research in Rwanda.

Public health relevance
NARRATIVE Sub-Saharan Africa carries the highest burden globally of both HIV and cervical cancer (CC). Cervical Cancer is 6-fold more common in women with HIV, and is preventable via vaccination prior to HPV exposure, or through screening and treating women for HPV infection or cervical lesions. Rwanda is a low-income country with high burden of both HIV and cervical cancer and limited research capacity for investigators to conduct high impact research in this area. Building research capacity for investigators to study this population at a dual burden of disease could contribute towards strategies to mitigate that burden